PROTROPIN ADMINISTERED DAILY AND TIW TO PATIENTS WITH GROWTH HORMONE DEFICIENCY

Daily administration of Protropin is compared with thrice weekly administration in children with growth hormone deficiency to determine which dosing schedule promotes more rapid growth.